Sleep-Wake Cycles of Individuals with Inflammatory Bowel Disease

PROJECT SUMMARY
The purpose of this Ruth L. Kirschstein National Research Service Award (NRSA) Individual Pre-Doctoral
Fellowship in Nursing Research (F31) application is to provide research training for Ms. Yoo, a beginning
second-year doctoral student at the University of Washington (UW). The long-term goal of this training is for
Ms. Yoo to develop into an independent researcher at a research-intensive academic setting with a program of
research focused on improving health outcomes of persons with inflammatory bowel disease (IBD) through the
development of self-management strategies that address biological and socio-ecological factors. The costs of
care and prevalence of IBD, a chronic gastrointestinal (GI) disease, have been rising in the United States. IBD
symptoms (e.g., diarrhea, abdominal pain) negatively impact quality of life, work productivity, and school
attendance; thus, there is a clear need to explore behavior modifications (e.g., behavior-influenced sleep-wake
cycles) to mitigate the symptoms of those with IBD. Although animal models have shown the adverse effects of
disrupted sleep-wake cycles on the GI system (e.g., intestinal dysbiosis), there is little research that focuses on
the impact of inconsistent sleep-wake cycles on IBD health outcomes as well role of external socio-ecological
factors (e.g., work and family obligations) on sleep-wake cycles of those with IBD. The aims of the proposed
study that employ both quantitative and qualitative methods are to understand the relationship between rest-
activity rhythm (RAR) characteristics and social jetlag with fatigue, sleep quality, GI symptoms, and disease
activity, and identify the social and societal factors that impact sleep-wake cycles. Unlike most IBD sleep
studies, this study will use objective actigraphy to measure RARs and social jetlag, and a qualitative portion will
provide additional insight from IBD participants on socio-ecological factors that impact sleep-wake cycles which
quantitative measures cannot fully capture. The socio-ecological model of health and sleep will guide the
research project to consider the societal, social, and individual level impacts of sleep-wake cycles on IBD
outcomes. The principal investigator will collect prospective data on 24 IBD participants from the University of
Washington Medical Center's gastroenterology clinic and leverage existing data on 26 IBD participants from a
previous study focused on nighttime sleep outcomes, resulting in a total of 50 participants. This award will
prepare a pre-doctoral trainee through advanced coursework and direct research experience, qualitative and
quantitative methods, focused analysis of RARs, and discovery of the relationships among three different
concepts related to sleep-wake cycles and IBD-related health outcomes. The findings generated from this
investigation will provide foundational knowledge for building a new program of research in self-management
and symptom science in IBD.

Public health relevance
PROJECT NARRATIVE This proposed study provides information on the influence of sleep-wake cycles on Inflammatory Bowel Disease (IBD), a chronic autoimmune disease, that impacts the quality of life of an estimated 3 million Americans. The proposed study presents insights on the social and societal factors that impact sleep-wake cycles of those with IBD as well as the relationships between 24-hour rest-activity rhythms and social jetlag with IBD health outcomes, such as fatigue, and disease activity. The findings from this project will assist in future research on interventions that promote stable sleep-wake cycles for persons with IBD.